Exploring how bystanders' own intoxication influences their ability to intervene appropriately

Abstract
The current diversity supplement extends the aims of the parent grant (R15AA028910). The parent grant
is a 3-year R15 AREA project designed to create the novel Bystander Intervention for Problematic Alcohol Use
Measure (BIPAUM), with specific aims to 1) develop the measure and establish the psychometric properties of
bystander intervention for PAU, and 2) validate the BIPAUM. To address specific aim one, 20 focus groups have
been conducted among diverse college students from various groups (i.e., White, Black/African American, Latinx,
Middle Eastern/Arab, Asian American, men, women, LGBTQIA+, sorority members, fraternity members) to
identify realistic drinking scenarios college students have experienced and identify opportunities for intervention.
Student feedback will inform item development of the BIPAUM measure which will then go under the process of
validation to ultimately create a validated measure of bystander behaviors for problematic alcohol use (PAU).
Supplemental questions were added to the focus group guide that extends previously unforeseen components of
this study. While the parent grant briefly asks about risky situations that may arise as a result of PAU, it does not
examine how bystander intervention may look different depending on the situation (i.e., events leading to sexual
assault [SA]). The parent study also does not examine events leading up to potential alcohol-related or facilitated
risky situations (i.e., in SA, consent-seeking or coercive strategies involving alcohol). Lastly, the parent study
does not examine the influence of bystander intoxication on ability to notice, interpret, assume responsibility, or
intervene in these drinking situations. These additional questions will help enhance our understanding of realistic
drinking situations among diverse college students and potential consequences that may arise (i.e., alcohol-
facilitated sexual assault) and inform our measure of bystander behavior for PAU. This supplemental application
is important in identifying events leading up to harmful consequences of problematic drinking and ways to
intervene that will contribute to the literature on bystander intervention and alcohol-facilitated sexual assaults.
Creating highly realistic and informed bystander interventions may more effectively lead to increases in helpful
bystander behaviors. This supplemental application promotes diversity in health-related research by providing
targeted mentorship and training to an early scientist in the field who will be able to develop their methodological
skills, gain research experience leading the proposed activities, and gain opportunities to be involved in
manuscript development and dissemination of findings. Lastly, the candidate will write an f31 grant after all
proposed activities are completed to continue the efforts of developing and implementing a brief bystander
intervention for alcohol-facilitated sexual assault.

Public health relevance
Project Narrative Posing significant physical and mental health problems for college students, problematic alcohol use (PAU) generally occurs in group settings, but often people do not stop others from pursuing this harmful behavior. We do not understand why, when and where this lack of response occurs, because we currently have no way to assess bystander behaviors in these situations. This project will develop an appropriate measure related to PAU bystander behaviors that can be used to create, implement and evaluate interventions for bystanders, ultimately reducing the amount of harm college students may experience as a result of PAU.